NAVIGATE-Kidney: Reducing Type 1 Error Rate by Modifying Methods to Individually Randomized Group Treatment Trial

PROJECT SUMMARY/ ABSTRACT
Compared to non-Latinx White individuals, Latinx individuals (gender-inclusive term; includes Hispanics,
Latino/a/e) have 2-times the risk of kidney failure and face a disproportionate burden of structural racism and
kidney health disparities. Latinx individuals are less likely to receive pre-dialysis nephrology care compared to
non-Latinx White individuals and as a result, are less likely to initiate person-centered kidney replacement
therapy (KRT), such as kidney transplantation or home dialysis. Latinx individuals are instead more likely than
non-Latinx White individuals to begin KRT with a central venous catheter (CVC), which has a higher risk of
mortality (1.4-1.5-fold) and fatal infection (1.5-2-fold) compared to an arteriovenous fistula or graft. Our
community-partnered research team developed and tested NAVIGATE-Kidney, a multi-level, language and
culturally concordant community health worker (CHW) intervention for Latinx individuals with kidney failure who
receive maintenance hemodialysis. We hypothesize that our NAVIGATE-Kidney intervention will reduce the
composite primary endpoint, defined as time to transition to KRT and CVC use or death. Our funded parent
grant (U01 DK137272-01) allows us to move beyond dialysis center interventions by providing support to
Latinx individuals with chronic kidney disease stage 4. As part of the ERASE-KD consortium, the NAVIGATE-
Kidney protocol was reviewed by the NIH Office of Disease Prevention (ODP). The NIH ODP stated that this
study should be modified to an individually randomized group treatment (IRGT) trial to account for the
intraclass correlation (ICC) induced by the nesting of patients within the CHWs; otherwise, the analysis will
lead to an inflated type 1 error. The team modified the study design and it is now an IRGT; however, without
supplemental funding, we can only account for an ICC of 0. When clustering exists, it is very unlikely that the
ICC will be 0. To account for an ICC, we must increase our power by increasing the number of CHWs from 4
to 6. This will allow the team to detect a hazard ratio of 0.50 for a range of ICCs. There is no preliminary data
nor literature available to provide a reasonable estimate of the ICC of time to event endpoints of participants
with the same CHW for the population of our study. Findings from this IRGT will inform the ICC of future CHW
interventions including those interventions that are part of the ERASE-KD consortium. The team will work with
the ERASE-KD consortium and the NIH ODP to develop research methods for time-to-event IRGT. This
change constitutes an opportunity to advance kidney disease health equity science.

Public health relevance
PROJECT NARRATIVE The Latinx community bears a disproportionate burden of chronic kidney disease, and they are less likely to start recommended kidney replacement therapy, such as kidney transplant or home dialysis, compared to non- Latinx White individuals. Our funded parent grant (1U01DK137272-01) allows us to conduct a patient-level randomized controlled trial of NAVIGATE-Kidney, a multi-level, community health worker intervention for Latinx with kidney disease, that will reduce kidney health disparities. The proposed supplement responds to the NIH Office of Disease Prevention (ODP). The NIH ODP conducted a thoughtful review of our protocol and recommended we modify our study design to an individually randomized group treatment trial.